IN VITRO MODELLING SYSTEM FOR TISSUE TESTING

Working on new in vitro modeling system for tissue testing. Tissues cultures so for include intestinal mucosal cells, adipose, cartilage, bone, bone marrow, epithelium, tongue, anti-pituitary cells and thyroid. All cells grown within this material display normal differentiated tissue characteristics. Now characterizing the biological effects of 3D growth on different cells lines using immunohistochemical techniques.